Pediatric Research Optimizing Methods in Stakeholder Engagement (PROMISE)

PROJECT SUMMARY
The Pediatric Research Optimizing Methods In Stakeholder Engagement (PROMISE) Core will support
Research Expanding Access to Child Health (REACH) COBRE investigations by fostering engagement of
communities and investigators as equal co-participants throughout the research process. Communities are
powerful and essential partners in the effective, comprehensive, and equitable transformation of pediatric care.
Community stakeholders possess a valuable and often rich appreciation of the multilevel, complex social realities
that contribute to disparities in health and health care for children and families. Community-engaged research
holds the potential to address disparities in health and health care, yet few investigators pursue partnerships and
community participation because of a lack of training and perceived barriers including the time commitment and
difficulty generating empirical publications from such research. The PROMISE Core will support investigators in
taking a community-based, participatory approach in their research and address the barriers that dissuade
investigators, especially early career investigators, from engaging in this approach. Specifically, the PROMISE
Core will establish an institutional infrastructure that prepares investigators by: a) training them in community-
engaged research frameworks, b) forming and facilitating ongoing project work groups for specific investigators
and relevant community stakeholders, c) providing ongoing technical assistance/consultation, and d) maintaining
a data repository to support investigators in expediently generating rigorous evidence in response to community-
priority questions. This institutional infrastructure will apply a framework for the successful engagement of
community stakeholders and investigators in a process of equal participation in all aspects of the research
process, including co-construction, co-execution, and shared interpretation and dissemination of findings. The
PROMISE Core aims to: 1) create a dynamic, responsive infrastructure to support investigators in their pursuit
of conducting stakeholder-engaged intervention-focused research to address pediatric health disparities, 2)
prepare and support investigators in participating in stakeholder-engaged research and producing, translating,
and utilizing scientific knowledge to improve community health, and (3) manage and sustain these resources to
broadly support community-engaged research to address health disparities. Dr. J. J. Cutuli will direct the
PROMISE Core, supported by a core Internal Advisory Committee, the REACH Stakeholder Advisory Committee
and the existing Delaware Clinical and Translational Research ACCEL Program Community Engagement and
Outreach Core Community Advisory Council. The PROMISE Core will bring community expertise to bear on
questions of inequity in pediatric health and health care, enabling the REACH Center to achieve its overall goals
of developing, evaluating, and implementing new interventions and models of care to overcome the complex
socioecological factors that contribute to health inequity.